EXAMINATION OF CHINESE IMMIGRANT PARENTS' BELIEFS ABOUT CHILDREN'S SOCIAL DEVELOPMENT THROUGH PLAY: A MIXED METHODS EXPLANATORY SEQUENTIAL STUDY

The goal of this study is to provide a deeper understanding of Head Start Chinese immigrant parents’ beliefs about children’s social-emotional development, the value of play, and implications for Chinese children’s socialcompetencies.